Integrated Clinic and Patient Technology-Enabled Program to Reduce the Risks of Cardiometabolic Disease Among Latinas with Prior Pregnancy Complications

Abstract
Nearly 40% of Latinas experience an adverse pregnancy outcome (APO) that places them at significantly
higher risk of developing cardiometabolic disease (CMD), including type 2 diabetes and/ or cardiovascular
disease. The primary care setting has been identified as a key locus for addressing this major public health
need, as primary care providers assume responsibility for the majority of care 6 weeks after delivery. Although
currently not widely available, digital technologies have been recommended as a solution for expanding access
to such preventive services in primary care. This lack of availability of digital technologies for women with prior
APOs is a particularly noteworthy gap among primary care clinics serving large Latina populations, given the
many historical disparities experienced by Latinas in health, coverage, and access to care. To the best of our
knowledge, the proposed SBIR would be the first-ever effort to create and test an integrated clinic platform and
patient app to enable primary care practices to deliver behavior-change programming to support Latinas in the
5 years after their APO. The integrated system will be developed using a user centered design approach
incorporating feedback from both paraprofessional staff who will deliver the program and provide social
support, and Latina patients, with the goal of successfully marketing the program to primary care clinics serving
Latinas. The project is innovative in its comprehensive approach that addresses the 5 major APOs associated
with future CMD, a clinic platform that overcomes key barriers to delivering lifestyle interventions in primary
care, reliance on paraprofessionals to deliver the program, and combining an individualized approach for
patients with a population health approach for primary care clinics. Specific aims are: Aim 1: Develop a clinic
platform to integrate with our existing patient application to promote healthy behaviors among Latinas with
recent APOs predictive of CMD; Aim 2: Develop and test digital tools and digital training toolkit for the new
clinic platform for use by paraprofessionals (e.g. CHWs, medical assistants, health educators) and test the new
features incorporated in the existing patient app; and, Aim 3: Evaluate feasibility, usability, and acceptability of
the integrated clinic and patient application. The team includes a multicultural and multidisciplinary group of
clinicians and researchers who have collaborated on prior technology-based interventions for women in the
postpartum years. Hola Bebé, Hola Salud addresses a large unmet public health need with significant
commercial potential among primary care clinics serving Latina populations. Our B2B approach is consistent
with emerging trends on population health and value-based payment in primary care.

Public health relevance
Narrative The proposed Phase I project aims to develop and test Hola Bebé Hola Salud, a culturally sensitive digital health intervention consisting of an innovative primary care clinic platform linked with a patient app to promote healthy behavioral change in Latina patients with prior pregnancy complications associated with future risk for diabetes and cardiovascular disease. Hola Bebé, Hola Salud addresses an important unmet market need among primary care clinics and overcomes access barriers on the part of Latina patients. Hola Bebé Hola Salud is innovative in three important ways, namely: 1) it is the first ever integrated digital clinic platform and patient app for behavioral change in the postpartum years for Latina women with prior pregnancy complications; 2) it addresses the 5 major pregnancy complications associated with future diabetes and cardiovascular disease instead of addressing singly; and 3) it relies on a clinic application that overcomes key barriers to delivering lifestyle interventions in primary care as is delivered virtually by paraprofessional staff, who are trusted members of Latina patient’s primary care clinic.